Characterization of candidate histone methyltransferases

We conducted a comprehensive analysis of transcription of two candidate histone methyltransferases in human and mouse tissues, showing tissue-specific expression of alternatively spliced and read-through transcripts. We conducted several yeast two-hybrid screens to identify protein-binding partners for the putative histone methyltransferases. These screens yielded several intriguing candidates that are being characterized further by biochemical and genetic methods. We have constructed a conditional knockout plasmid to generate a knockout mouse model lacking one of the putative histone methyltransferases located on a frequently deleted chromosomal region.